Mechanistic and Bioinformatics Core

SUMMARY – CORE C
Trained immunity is characterized by pronounced changes in the epigenome, gene expression, metabolism, and
cell dynamics. The investigators associated with this Program Project will perform comprehensive studies on
trained immunity in the context of transplantation. To safeguard the appropriate implementation of trained
immunity assays across the different projects, we have established a Mechanistic and Bioinformatics Core
(Core C). Core C will operate at Mount Sinai and be directed by Dr. Jordi Ochando, an internationally
recognized transplant immunologist and one of the founders of trained immunity in organ transplantation
research. The Core team will provide expertise and in-house optimized protocols to profile immune cells and
biologically validate promising therapeutic targets. Importantly, this Core will also safeguard bioinformatics and
biostatistics analyses and general data management and storage. Lastly, Core C will implement and manage
Labguru, a laboratory management system used to track samples, record, and share protocols and data, and
keep inventory.